A novel, semi-automated self-monitoring feedback system for health promotion in community settings

PROJECT SUMMARY
Weight management interventions delivered in community settings demonstrate weight losses of ~4% of
baseline weight, smaller than the 8-10% observed in effectiveness trials. The provision of weekly feedback
related to self-monitoring of dietary intake, physical activity, and weight improves weight loss outcomes in
adults with obesity; however, this feedback is often not provided in interventions delivered in community
settings due to lack of training and time. To support effective feedback provision in community interventions,
we propose to develop a semi-automated self-monitoring feedback system that can be integrated into a range
of community settings. First, to address the lack of empirical evidence regarding optimal feedback construction,
Aim 1 will focus on optimizing the efficacy of feedback messages (including development of a feedback library
and an optimized algorithm for feedback provision). In Study 1, we propose to use a highly efficient micro-
randomized factorial trial design to evaluate the impact of different types (in relation to behavioral target and
interactivity) and amount of feedback on weight change in 300 adults with overweight or obesity. Participants in
this study will receive a core Weight Loss 101 session and will be asked to self-monitor dietary intake, physical
activity, and weight daily using study-provided tools (a Fitbit activity monitor, Fitbit e-scale, and the Fitbit
smartphone app). Each week for 16 weeks participants will receive basic feedback on the frequency of their
self-monitoring of dietary intake, physical activity, and weight and their weight trajectory, and will be randomly
assigned to receive (or not receive) each of four additional feedback components (calorie goal attainment, diet
quality, physical activity goal attainment, and prompted goal setting). We will use mixed-effects models to
investigate the impact of each feedback component on weight change (primary outcome) and on proposed
mechanisms (adherence to self-monitoring and to caloric intake and physical activity goals) during the week
after it is received. We will also investigate the impact of the number of feedback components received,
potential moderators of feedback efficacy (e.g., age, sex/gender, race/ethnicity, socioeconomic status, social
support, food security) and whether different combinations of feedback are more effective when individuals are
doing well in the program (i.e., meeting program goals) versus when they are not doing well, allowing us to
develop personalized algorithms for feedback provision. For Aim 2, we will employ user-centered design
methods to develop, refine (via iterative development/testing cycles in Study 2), and conduct “real world”
usability testing with community intervention facilitators (Study 3) of a semi-automated self-monitoring
feedback system that aims to combine the efficiency of computer automation with the expertise of target users.
Community intervention facilitators will be able to use this system to quickly develop effective self-monitoring
feedback for delivery of this essential treatment component across a range of community intervention settings,
broadly improving access to effective treatment for adult overweight and obesity.

Public health relevance
PROJECT NARRATIVE The current project is directly relevant to NIDDK’s mission and vision to pursue compelling research in obesity as well as the larger public health goal of reducing the prevalence of obesity in the United States. Research has clearly demonstrated that the provision of weekly feedback related to self-monitoring of dietary intake, physical activity, and weight can improve weight loss outcomes in adults with obesity; however, this feedback is often not provided in interventions delivered in community settings due to lack of training and time. The current study proposes to develop a semi-automated self-monitoring feedback system that can be ultimately integrated into a range of community settings, greatly improving access to effective treatment for obesity.